Administrative and Enrichment Core

SUMMARY
The Administrative Core coordinates all activities for the Core Center for Musculoskeletal Biology and
Medicine (CCMBM) so as to comply with all regulatory requirements, enhance research productivity, facilitate
efficient adoption and use of state-of-the-art technologies and computational approaches, expand the research
field, promote collaborative research, and develop innovative projects and investigators. The goals of the
Administrative Core are to: 1) provide strong scientific leadership for a broad, diverse, and sustainable CCMBM
community, 2) provide administrative management, fiscal oversight, and evaluation and reporting of all CCMBM
activities, 3) coordinate and integrate CCMBM activities and communications to serve MSK investigators, and
4) manage the Enrichment Program to maximize the impact of CCMBM resources on MSK research. The
services provided by the Administrative Core are grouped into 7 general categories, including leadership, fiscal
management, membership activities, reporting, communications, Enrichment Program activities, and Enrichment
Program funding. The Administrative Core will be led by a Director (Alliston) and Associate Director (Nissenson),
who are assisted by a Center Operations Team, the Internal Executive Committee, and the CCMBM Advisory
Board. The Administrative Core leverages the abundant and outstanding resources at UCSF and in the
University of California to accomplish these goals, creating synergies that benefit musculoskeletal investigators
and the scientific community more broadly. The ability of CCMBM to deliver high quality professional core
services in an innovative, responsive, and cost-effective manner benefits immensely from the UCSF Research
Resource Program, which organizes systems for the management of Core services and finances and training
for Core staff. We also plan to build on the developed UCSF-based CCMBM foundation to expand, integrate,
and support a sustainable, diverse community of MSK investigators throughout the University of California
system. As such, the activities of the Administrative Core not only support the CCMBM but are the cornerstone
for the integrated musculoskeletal ecosystem at UCSF, and increasingly at a regional level.

Public health relevance
PROJECT NARRATIVE Not Applicable